Roles for Intracellular pH Dynamics in Cancer

Abstract
Although cancers have a constitutively increased intracellular pH (pHi) that enables disease progression, the
molecular mechanisms mediating pHi-dependent cancer cell behaviors are understudied and incompletely
understood. During the funding period we bridged protein electrostatics and cell biology to identify molecular
mechanisms for pHi regulating tumorigenesis and metabolic reprogramming, and for conferring cancer-
promoting functions of somatic mutations encoding charge changes in proteins. Our competing renewal applies
our expertise in new directions to address two gaps in our understanding of pHi dynamics and cancer. First is
how pHi dynamics can directly regulate gene expression. Our previous work resolved how pHi dynamics can
regulate protein-phospholipid and protein-protein binding; however, how pHi dynamics can regulate protein-DNA
binding, despite nuclear and cytosolic pH being similar, remains unknown. In Aim 1 we test a new idea on pHi
titration of a histidine in the DNA-binding domain of transcription factors that forms hydrogen bonds with
nucleotides in conferring target gene selectivity. This idea is applicable to at least 65 transcription factors with a
nucleotide-binding histidine. Focusing on three transcription factors from different families, FOXC2, SOX4 and
MAX that have roles in cancers, we will test the hypothesis that dysregulated pHi dynamics in cancer cells
contributes to transcription factor-DNA binding selectivity for enabling cancer cell behaviors. We will
resolve pH regulated affinities of DNA binding domains to recognized DNA motifs, identify pH-dependent
genome-wide binding preferences, and determine pH regulated transcription factor-DNA binding selectivity in
cancer cells. Additionally, we apply our predictions on pHi regulated selectivity of transcription factor-DNA
binding by testing targeting the nucleotide-binding histidine to reactivate a tumor suppressor pathway in cancer
cells. A second gap in our understanding is the role of pHi dynamics and heterogeneity in tumorigenesis. Based
on our preliminary data of intercellular pHi heterogeneity in clonal cancer cell spheroids and organoids of cancer
cells from human biopsies, and established roles for pHi dynamics in epithelial plasticity, cell migratory capacity,
and stem cell differentiation, in Aim 2 we will test the hypothesis that pHi heterogeneity distinguishes tumor
cell phenotypic heterogeneity. We will determine whether pHi heterogeneity reflects distinct cell phenotypes
and identities in spheroids of clonal colorectal cancer cells and organoids derived from biopsies of human
colorectal tumors, by transcriptomics profiles generated by single cell RNA-seq and genetically changed pHi. To
resolve pHi dynamics and heterogeneity during tumorigenesis we use a Drosophila line we generated expressing
a genetically encoded pHi biosensor that allows longitudinal imaging of pHi dynamics in vivo, which cannot be
achieved with mouse models. Significant outcomes of our studies include showing for the first time that pHi can
regulate transcription factor-DNA binding selectivity, new insights on emergent tumor cell properties, and clinical
promise for targeting cancer cell pHi for prognostic value and selective delivery of therapeutics.

Public health relevance
PROJECT NARRATIVE Targeting unique features of cancer cells is a preferred therapeutic strategy to inhibit metastatic progression while limiting off-target effects in normal cells. We are testing new ideas on how the unique feature of increased intracellular pH (pHi) in cancers compared with normal adult cells can be targeted to limit cancer metabolism and tumorigenesis. Our expected outcomes are substantial new views on the importance of increased pHi in cancer progression that will impact new therapeutic strategies to limit progression of cancers from different tissue origins and genetic backgrounds.